A Client-Based Outcome System for Individuals with Lower Limb Amputation

Project Summary
The primary goal of the proposed research is to advance the quality of care provided to people with lower
limb amputation (LLA) by developing a state-of-the-art, dynamic measurement system that can be incorporated
into clinical practices, research studies, and electronic health record systems. Performance-based
measurement of important health outcomes, like prosthetic mobility, is widely acknowledged as an important
element of professional practice and a primary contributor to positive patient outcomes. Standardized
performance-based measures are well suited to measuring clinical patients, but they are inhibited by a
structure that requires a patient to complete a large number of tasks, many of which provide limited value to
the clinical assessment. Modern measurement methods, which have been successfully applied to enhancing
the quality and efficiency of patient-reported measures, can be extended to address inefficiencies in
performance-based testing. In this project, we apply advances in psychometric modelling and computer
technology to create a dynamic measurement system that targets the capabilities of each individual patient.
In Aim 1, we will develop a bank of tasks suited to measuring mobility of people with LLA in clinical
settings. A large, diverse sample of 500 prosthetic limb users will be recruited in a national cross-sectional
study to test candidate tasks. Results will be quantitatively analyzed using item response theory (IRT) to create
a calibrated bank of performance tasks that can be targeted to patients with similar characteristics (eg, people
with LLA due to diabetes) using fixed-length task sets, or targeted to individual patients using computerized
adaptive testing (CAT). In Aim 2, we will conduct statistical simulations to maximize the efficiency of the CAT
algorithm. We will use information from patient-report outcome measures to identify the first task and unique
stopping rules to ensure patients with very high or very low mobility are not unnecessarily burdened. We will
develop an application to allow clinicians and researchers to administer the measure, and software to facilitate
integration into electronic health record systems. In Aim 3, we will evaluate the reliability, validity, and efficiency
of the developed system for measuring mobility in people with LLA. A diverse sample of 100 prosthetic limb
users will be recruited to participate in a repeated-measures study. We will compare results from the
developed system to existing measures of mobility, balance, and physical function.
Successful completion of this project will provide a valid, reliable, interpretable, and efficient tool for
measuring mobility outcomes in people with LLA and a model for enhancing performance-based measurement
in other clinical populations.

Public health relevance
Project Narrative Valid, reliable, and efficient measurement of relevant health outcomes is needed to facilitate improvements in clinical care, research, and quality-of-life for people with lower limb amputation. Development of novel, performance-based instruments using modern measurement theory will enable researchers to more effectively study health outcomes and interventions intended to address functional impairments, activity limitations, and participation restrictions present among people with limb amputation. Application of developed measures using adaptive computer technologies will allow clinicians to efficiently evaluate patients' health outcomes, select interventions best suited to each individual patient, and provide high quality, evidence-based care.